LESCH-NYHAN SYNDROME AND RELATED PURINE METABOLISM DISORDERS

To further elucidate the defects responsible for Lesch-Nyhan disease. The impact of various therapeutic interventions upon these abnormalities will be evaluated.